Use of the electronic health record to target a patient navigation intervention preventing loss to follow up in the treatment of urinary stone disease

PROJECT SUMMARY
This is a K23 award application for Dr. David Bayne, an Assistant Professor at UCSF. His career goal is to
become a clinician-researcher focused on studying and reducing disparities in treatment outcomes for urinary
stone disease (USD). This award will provide him with training and research experience to: (1) leverage
electronic health record (EHR) data to streamline the identification of patients at risk for being lost to follow up
(LTFU) after diagnosis of USD in the emergency department (ED); (2) elucidate stakeholder perspectives on
root causes of, and potential solutions for, LTFU; and (3) evaluate acceptability and feasibility of early risk
identification paired with patient navigator support as a pilot intervention to reduce LTFU for USD. Dr. Bayne
has assembled an ideal team composed of co-primary mentors, Dr. Marshall Stoller and Dr. Charles Scales,
experts in clinical trial design and implementation for USD; and co-mentors Dr. John Neuhaus, an expert in
biostatistics and prediction model development, Dr. Sara Ackerman, an expert in application of qualitative
research methods, and Dr. Lilia Cervantes, an expert in clinical trial design and implementation for patient
navigation interventions.
Although disparities along lines of socioeconomic status (SES) have been consistently described in the
diagnosis and treatment of USD, interventions to mitigate these disparities are lacking. Dr. Bayne will build on
findings from his prior work showing a consistent, independent association between delays in urologic care for
USD and multiple EHR-derived predictors that correspond to low SES (e.g. insurance, demographic
information, community level data). Predictive statistical models will be employed to streamline the
identification of patients at risk for LTFU for USD upon placement of an outpatient referral to urological care in
the ED by leveraging EHR-derived clinical and social data covariates (Aim 1). In addition, semi-structured
interviews with patients and their providers will be conducted to elucidate themes contributing to LTFU for USD
(Aim 2). A paired LTFU risk identification and patient navigation intervention will be developed and piloted to
assess for acceptability and feasibility (Aim 3). This work will be the foundation of an R01 proposal for a
randomized control trial to assess LTFU risk identification and tailored patient navigation as an intervention to
reduce disparities in care delays in the treatment of USD.
Through a focused program of mentored training and coursework, the candidate will gain new and
necessary skills to deliver these research aims and advance in his career and professional development.
These skills include: (1) prediction modeling with advanced biostatistics, (2) qualitative and mixed methods
research, and (3) intervention development for clinical trials. These skills will enable Dr. Bayne’s transition to
independence by uniquely positioning him to identify, study, and intervene upon factors contributing to
disparities in USD care outcomes in low SES patients.

Public health relevance
PROJECT NARRATIVE Disparities in urinary stone disease (USD) treatment among individuals of low socioeconomic status are increasingly recognized, but there remains a vital need to develop interventions to combat these inequities. This proposal’s objective is to utilize clinical and social data derived from the electronic health record (EHR) to streamline the identification of patients with urinary stone disease at risk for loss to follow up (LTFU) after presentation to the emergency department, and to develop a targeted patient navigation intervention for patients with USD. This approach requires application of prediction modeling, qualitative and mixed methods research, and clinical trial development and evaluation, and it includes a pilot clinical trial that will provide vital preliminary data for a randomized control trial evaluating a paired risk identification and patient navigation intervention to prevent care delays for USD.